Targeting splicing vulnerability of neuroblastoma

ABSTRACT
Neuroblastoma is responsible for 15% of cancer related deaths in childhood cancers. Although intensive
combined chemotherapy and immunotherapy has improved the outcomes to 50% for high-risk patients, it comes
at the expense of significant long-term side effects. Thus, safer and more effective therapies are badly needed
for improving survival and life quality of high-risk cancer patients. Pre-mRNA splicing is a process coupled with
active gene transcription and catalyzed by spliceosome for production of mature mRNAs. The dysregulated pre-
mRNA splicing existing across all types of cancer including neuroblastoma, which acts as a critical pathway in
tumorigenesis and may consequently create vulnerabilities for cancer cells. Our recent studies revealed that the
splicing factor RBM39 is exquisitely essential to neuroblastoma. Indisulam, a “molecular glue” that selectively
recruits RBM39 to the CRL4-DCAF15 E3 ubiquitin ligase for proteasomal degradation, is highly efficacious
against neuroblastoma, leading to significant responses in multiple high-risk disease models, without overt
toxicity. We hypothesize that disruption of the dysregulated spliceosome by targeted degradation of RBM39 is a
promising therapeutic strategy against neuroblastoma. Our major goal is to extensively test this hypothesis for a
near future clinical trial through the following Specific Aims: 1) To investigate the efficacy of
chemoimmunotherapy in combination with indisulam in preclinical NB models; 2) To determine the mechanism
by which indisulam induces durable and complete responses in immune competent setting; 3) To determine the
mechanism of disease relapse after indisulam therapy in the immune-deficient setting. Our studies will be a
deeper understanding of the splicing dependency of cancers driven by oncogenic transcription factors and the
identification of novel therapeutic approaches against them. Our proposed research will establish the foundation
to translate our findings to a near-term clinical trial, which has the potential to have a significant impact on high-
risk neuroblastoma patients who run out of therapy options.

Public health relevance
Projective Narrative This project is to understand the mechanism of exceptional efficacy of RBM39 degrader indisulam in high-risk neuroblastoma and develop combination therapies using preclinical neuroblastoma models, thereby establishing the foundation for a near-term clinical trial to treat relapsed and refractory neuroblastoma patients.